26- & 39-Week Toxicity Studies of ANS-6637 in Rats and Monkeys (respectively) to Enable 6+ Months Dosing in Alcohol (and other Substance) Use Disorder Phase 3 Studies

PROJECT SUMMARY The Surgeon General has stated “substance misuse remains a national public health crisis”1. In 2015, 15 million adults had Alcohol Use Disorder (AUD) in the United States (US)2. However, less than 7% with AUD received treatment3. In the US, 88,000 people die from alcohol related causes4 and the economic burden of AUD is over $250 billion per year5. To solve help the national public health crisis of AUD and more broadly of substance use disorder (SUD), more tools including new pharmacotherapy treatments for SUD are needed. Amygdala is developing the novel treatment, ANS-6637, for AUD and SUD. The proposed Specific Aims will generate chronic toxicity data required to establish appropriate treatment duration for ANS-6637 as a treatment for SUD. ANS-6637 is an orally bioavailable prodrug of the selective Aldehyde dehydrogenase 2 (ALDH2) inhibitor GS- 548351. In-Vitro and In-Vivo studies have demonstrated that ALDH2 inhibition suppresses the surge in dopamine release common to all addiction27. Pharmacology studies have demonstrated that ALDH2 inhibition reduces craving and drug-seeking behavior in multiple rodent models including reinstatement models of alcohol relapse. ANS-6637 has been studied in Phase 1 clinical studies in 135 human subjects. ANS-6637 had been evaluated in 28-day & 13-week rat & monkey toxicity studies which support clinical dosing of up to 3-months duration. Substance Use Disorders including AUD are chronic relapsing diseases. Therefore, treatments for SUD and AUD should be developed to be used for extended (i.e., more than 3-months) duration. For AUD clinical development, Food and Drug Administration (FDA) guidance calls for Phase 3 trials of 6-months duration29. Prior to human clinical studies of 6-months or more duration, or for marketed exposure of >1 month, FDA and the International Council for Harmonisation (ICH) Guidance require that sponsors conduct 6-months rodent and 9-month non-rodent repeat dose toxicity studies30,31. The Specific Aims of this grant application (chronic toxicity testing of 6-month duration in rodents and 9-month duration in non-human primates) will generate data required to assess if clinical studies of 6-months or longer duration with doses up to 600 mg QD can be conducted.

Public health relevance
PROJECT NARRATIVE To develop pharmacotherapies to treat Substance Use Disorders (SUDs), which are chronic relapsing diseases that have led to “a national public health crisis”1, FDA and ICH guidance requires clinical development include clinical studies of 6-months or more duration. Based on supportive pre-clinical and clinical results, Amygdala Neurosciences is developing ANS-6637 as a treatment for SUD including Alcohol Use Disorder, but because the current chronic toxicity data is based on 13-week studies, development is currently constrained to clinical studies of no longer than 3-months duration. The proposed Specific Aims (chronic toxicity testing of 6-month duration in rodents, and 9-month duration in non-human primates), if successful, would enable chronic dosing of ANS-6637 in clinical trials of 6-months or longer treatment duration and post approval labeled treatment duration of greater than 1 month, which could support approval of ANS-6637 for SUD and AUD resulting in a favorable impact on public health.